PHARMACOKINETICS OF TOBRAMYCIN ADMINISTERED BY DIFFERENT NEBULIZERS TO CF PTS

The aims of this study were 1) to determine which of three nebulizer systems could aerosolize sufficient tobramycin sulfate to achieve a peak sputum tobramycin concentration measured 10 minutes after the completion of nebulization in 85% of patients with CF and 2) determine whether the tobramycin concentration required to achieve a peak sputum tobramycin concentration is safe and well tolerated by the patients. This study has been completed and data is in analysis.